Johns Hopkins Human Temporal Bone Resource

Project Summary
Temporal bone research is essential for refining our understanding of the mechanisms of otologic disease;
however, the difficulty in accessing this tissue, the typically long processing times, and the expense have
contributed to a dwindling number of labs engaged in this work. In the 1920s, the first human temporal bone
laboratory in the U.S. was established at Johns Hopkins. The collection contains approximately ~1400 processed
specimens from donors with a range of otologic diseases that were obtained primarily in the 1920s through
1970s, but only a handful of studies have made use of this collection in the past 20 years. We propose to make
the collection more accessible to the scientific community and to re-establish the infrastructure for harvesting,
imaging, and processing new specimens with the intention of recruiting new donors from population-based
studies of aging in which participants have already consented to autopsies and brain donations being performed
at Johns Hopkins, as well as other clinical otological studies ongoing in the Baltimore Metro Region. We will
partner with faculty specializing in biological visualization, bilingual scientific communication, and mentoring
diverse scientists to develop inclusive outreach tools. We will also partner with Baltimore-based transcriptomics
resources to establish protocols for performing spatial transcriptomics analysis in nonhuman primate and human
temporal bones. We will approach these objectives with three Specific Aims: 1) Catalog, prioritize, and digitize
existing specimens from the Johns Hopkins Human Temporal Bone Collection; 2) Develop efficient harvesting,
rapid histology, and spatial transcriptomics workflows for new specimens and establish partnerships for collecting
specimens during autopsies performed on participants in epidemiological studies; 3) Education/outreach
activities to encourage other investigators to engage in temporal bone research.
The large temporal bone collection and the inner ear illustrations of Max Brödel at Johns Hopkins contributed
greatly to our early understanding of many diseases of the ear, such as the discovery of glomus bodies, the
histopathologic correlates of presbycusis, and innervation of the saccular maculae. The collection has also
shown enduring value, contributing to our understanding of the prevalence of a dehiscent superior semicircular
canal and arachnoid granulations as well as the role of melanin in cochlear and vestibular protection. Sharing
this valuable collection with other researchers while applying novel techniques in digital processing and
education will accelerate advances in and knowledge of otopathology. We look forward to reinvigorating this
tradition of excellence by developing a new collection, applying modern techniques, and integrating otopathology
with population-based studies that include comprehensive otologic testing and functional measures.

Public health relevance
Project Narrative Hearing and balance disorders affect millions of people worldwide, yet the underlying damage patterns in the ear are not understood well for many inner ear-related clinical problems. This project will develop a large human temporal bone collection as a resource for the scientific community to investigate the inner ear correlates of hearing and balance problems in a diverse population. The project will also refine methods for rapid processing of newly obtained temporal bones and create a multi-platform imaging and analysis pipeline for maximization of the information obtained from each specimen.